Heterogeneity of Satellite Cell Populations Play a Role in Improvements in PAD after Exercise Therapy

Abstract
Peripheral artery disease (PAD) is a major health problem worldwide. Patients with the disease have
atherosclerotic lesions which impair blood flow to their limbs resulting in complications such as non-healing
wounds and amputations as well as pain and decreased quality of life. While many medical therapies have been
established to slow disease progression through controlling risk factors, the two most effective treatments at
improving a patient’s status are surgical or endovascular repair and supervised exercise therapy. While exercise
is an ideal treatment due to its lower cost and non-invasive nature, the mechanisms by which it improves patient
outcomes are still not known preventing the development of an ideal therapeutic strategy. This proposal
investigates a novel mechanism by which skeletal muscle satellite cells mediate these observed improvements.
Preliminary data shows that satellite cells generate several different proteins which are associated with vascular
growth and drive migration in vascular cells. Histological staining of human samples shows that satellite cells
increase in patients that see improvements with exercise and the presence of satellite cells appears to be critical
for recovery in an exercise preconditioning murine model. Aim 1 will investigate the causal relationship between
satellite cells and exercise mediated recovery using an murine model in which satellite cells are selectively
ablated. Aim 2 will use single cell sequencing to investigate the heterogeneity of satellite cells in response to
exercise and determine which stimuli and which specific expression profiles are the most vasculogenic. Finally,
Aim 3 will quantify the expression changes and heterogeneity in satellite cells from PAD patients isolated before
and after supervised exercise therapy. The goal of this aim is to determine how differences in satellite cell
populations correlate with clinical responses in the patients. The ultimate goal of this project is to understand
the biology and response of satellite cells in response to exercise to help develop more effective exercise
regimens for patients with PAD.

Public health relevance
Project Narrative Peripheral artery disease occurs when impaired blood flow to the tissue results in pain, decreased mobility, amputations, and increased mortality. Supervised exercise is one of the most effective treatments at improving patient’s quality of life, yet the mechanisms for how it works are not well understood. This proposal investigates satellite cells, a muscle stem cell, as the potential mediator of this process and understanding changes in the satellite cell’s biology with exercise will allow us to develop better therapies to treat the disease.